Regulation of beta-cell homeostasis by DNA methylation and hydroxymethylation.

PROJECT SUMMARY/ABSTRACT
Diabetes has become a major public health crisis, afflicting nearly 30 million people in the United States, and
these numbers continue to rise at an alarming rate. Both type 1 and type 2 diabetes result from insulin
insufficiency, in large part due to loss of functional beta-cells. Significant research efforts are currently focused
on understanding beta-cell failure in diabetes, and developing effective therapeutic approaches to replenishing
the beta-cell deficit in diabetes. Despite significant advances in these aspects, challenges remain in development
of effective beta-cell therapies, primarily due to gaps in our current understanding of mechanisms that regulate
normal beta-cell development, function, and growth. Our recent work has identified DNA methylation as a pivotal
epigenetic mechanism that regulates beta-cell identity and function. Moreover, we found that DNA methylation
patterns defining functional beta-cell phenotype are disrupted in the diabetic beta-cells, suggesting dynamic
nature of DNA methylation. Our preliminary studies indicate that dynamic remodeling of DNA methylation (5-
methylcytosine; 5mC) via its conversion to a hydroxylated form (5-hydroxymethylcytosine; 5hmC) is essential for
beta-cell differentiation, function, and adaptive response. We hypothesize that stage-specific, appropriate
patterning of 5mC and 5hmC is critical for beta-cell homeostasis, and is disrupted in diabetes leading to beta-
cell failure. Thus, we seek to determine how enzymatic regulation of the balance between 5mC and 5hmC
governs functional beta-cell mass and affects diabetes susceptibility. We will employ mouse genetics, disease
models, human islet studies, and state-of-the-art genome wide epigenetic profiling methods to address the
following aims: In Specific Aim 1, we aim to establish the requirement of 5mC and 5hmC patterning in
differentiation of beta-cells from progenitors. Specific Aim 2 seeks to define the contribution of dynamic
remodeling of 5mC and 5hmC patterns in beta-cell replication and adaptive capacity. In Specific Aim 3, we
address if and how environmental factors like oxidative stress and metabolite variation can disrupt the beta-cell
5mC 5hmC landscape to drive beta-cell failure, and diabetes.
The proposed studies will delineate a novel regulatory module that governs beta-cell development and
growth, and establish a fundamental regulatory paradigm that link beta-cell environment, metabolism and
epigenome. Our work is likely to have a broad and significant impact by providing novel clues to promote beta-
cell differentiation, function, and expansion towards strategies aimed at beta-cell rejuvenation and replacement
for diabetes therapy.

Public health relevance
PROJECT NARRATIVE Diabetes is a disease afflicting millions of people worldwide, and results from the loss of functional insulin producing beta-cells. Approaches aimed at preservation and replenishment of beta-cells hold a lot of promise to reverse the beta-cell dysfunction and deficit in diabetes. The proposed studies aim to elucidate the regulatory pathways that govern beta-cell formation, function, and adaptation, and are disrupted in diabetes, to obtain a clearer understanding of diabetes pathogenesis and aid the development of effective diabetes therapies. !